Schistosome antigen induced modulation of metabolism

Project Summary
Globally, parasitic helminth infections inversely correlate with metabolic diseases, such as diabetes,
atherosclerosis, and obesity, but the parasite factors that are capable of modulating metabolic disease are
currently unknown. Diabetic patients are twice as likely as non-diabetic individuals to develop cardiovascular
disease, with more than 65% of diabetic patients dying from cardiovascular complications, thus there is a
critical need for identifying novel compounds capable of modulating insulin resistance, obesity, and
atherosclerosis in this population. Recent evidence has suggested that inflammation driven by macrophages is
associated with both obesity and insulin resistance, while atherosclerosis is accepted to be driven by lipid-
dependent chronic myeloid inflammation. Our laboratory has recently identified that Schistosoma mansoni
infection modulates the metabolic transcriptome of the myeloid lineage, and that this modulation is correlated
with protection from the development of insulin resistance, diabetes, and atherosclerosis in the ApoE-/- high fat
diet mouse model. Our lab and others have established that in vivo metabolic protection is dependent on
exposure to egg antigens, but the antigens sufficient to confer protection are unknown. To fill these current
knowledge gaps, we propose to perform proteomic analysis and screening to identify the antigens sufficient to
modulate macrophage metabolism. We will first 1) identify pools of antigens sufficient to modulate mature bone
marrow derived macrophage metabolism, and then 2) determine the subset of antigens sufficient to program
bone marrow precursors to generate immunomodulated macrophages in vivo. The data generated from these
studies will lay the foundation for future studies on understanding the role of helminth induced macrophages in
the long-term regulation of whole-body metabolism.

Public health relevance
Project Narrative It has recently been established that the rates of obesity, insulin resistance, and atherosclerosis are greatly reduced in areas of the world with chronic helminth infections, and animal models have suggested that this metabolic protection is due at least in part, to metabolic modulation of macrophages. The purpose of this study is to determine the helminth antigens that capable of modulating macrophage metabolism. The long-term goal is to identify antigens that can potentially serve as for new treatments of diabetes and atherosclerosis.